Phenotyping and Biospecimen Core

Phenotyping and Biospecimen Core Summary
The Phenotyping and Biospecimen (P&B) Core’s primary mission is to leverage two NIA-funded
centenarian studies by sifting through their study participants in identifying centenarian cognitive
superagers, offspring and offspring spouses for enrollment in the RADCO study, extending their
phenotyping with annual uniform neuropsychological testing, plasma biomarkers of Alzheimer’s
disease (AD), and facilitating and facilitating neuroimaging and post-mortem neuropathological
studies among willing participants. The P&B Core's successful conduct of its six aims is key to
RADCO’s investigation of centenarians and their offspring as models of cognitive resilience and
resistance to cognitive impairment and AD. Those 6 Specific Aims are: Specific Aim 1. Establish
a centenarian cognitive superagers (n=596), centenarians with normal cognition (n=230),
offspring superagers (n=480) and offspring spouses (n=144) sample with baseline
neuropsychological assessments, other phenotypic data, blood samples, and genetic and
biomarker data provided by 2 ongoing NIA-funded centenarian studies. Specific Aim 2. Perform
annual Covid-19-safe virtual neurocognitive assessments and other phenotypic data collection
uniform with the ILO study and LCCP measures. Also, to enhance the accuracy of the
neurocognitive assessments by performing interdisciplinary expert diagnoses consensus
conferences. Specific Aim 3. Employing REDCap, manage and perform QC, and make easily
but securely available all of the data collected and generated by the RADCO Cores and Projects,
including the neuropsychological, neuroimaging, neuropathologic phenotype and biomarker and
transcriptomic data. Specific Aim 4. To receive from the ILO+LCCP studies and then
longitudinally collect blood samples (centenarians annually, offspring, and offspring spouses
every other year) from RADCO participants for use by the two projects. To maintain samples in a
biorepository as a sharable resource. Specific Aim 5. Support the RADCO Neuroimaging Core’s
aims by recruiting RADCO participants for local neuroimaging and linking scan data to clinical
data. Specific Aim 6. Recruit RADCO participants for future brain donation, ensure that
postmortem brain removal and delivery occur quickly, and link clinical data to anatomic,
pathological, and molecular data generated by the P&B neuropathology efforts. These data will
inform the resilient and resistant phenotypes delineated in Project 1. Brain area-specific tissues
will be provided for RNA expression studies in Project 2.